Insights into EHMT1 Variants in the Neurodevelopmental Disorder Kleefstra Syndrome through Structural Dynamics and Functional Analysis

Euchromatic histone methyltransferase 1 (EHMT1, also known as GLP) is a key histone methylation writer
intricately associated with Kleefstra Syndrome (KS), a multifaceted neurodevelopmental disorder characterized
by intellectual disability, developmental delay, childhood hypotonia, distinctive facial features, and comorbidities,
including autism spectrum disorders. Its modular structure encompasses the ankyrin repeat scaffolding domain
responsible for methyl-lysine recognition (histone reader function) and the SET catalytic domain governing
histone methylation (writer function). Despite the identification of numerous mutations in patients, their precise
effects on EHMT1 function and direct links to pathogenicity remain elusive. As such, most are annotated as
variants of uncertain significance (VUS). To enhance EHMT1 genomic variation interpretation and uncover
novel insights into its structure-function relationship, we have harnessed a comprehensive computational
approach to perform deep variant phenotyping, which integrates mechanisms rooted in sequence, structure,
and dynamics. Through this approach, we have identified domain-specific metrics and reclassified KS variants
within the SET domain. In this proposal, we aim to perform the first in-depth comprehensive deep variant
phenotyping of KS-associated variants within the ankyrin repeat domain and further elucidate the structure-
function relationship of variants within both the SET and ankyrin repeat domains to better understand
pathophysiological mechanisms underlying the disease. Our CENTRAL HYPOTHESIS is that KS-associated
genomic variants within EHMT1 alter structural dynamics as well as biochemical and biophysical properties
to impact domain-specific functions. The rationale is that comprehensive investigations into the biochemical,
biophysical, and structural dynamics of KS-associated genomic variants within the EHMT1 SET and ankyrin
domains will reveal detailed mechanisms underlying the disruption of domain-specific functions, providing
novel insight into the molecular basis of KS. To test our central hypothesis, we propose two interrelated, yet
independent AIMS: (1) to define the impact of KS-associated genomic variants within the ankyrin domain on
the structural dynamics of EHMT1 using deep variant phenotyping and (2) to elucidate the underlying
biochemical and biophysical mechanisms of EHMT1 dysfunction caused by KS-associated genomic variants.
These findings will establish crucial foundations for subsequent investigations involving cell-based and animal
model studies. Ultimately, our discoveries will have the potential to guide future therapeutic strategies aimed
at ameliorating the impacts of KS-associated variants on EHMT1 function and, by extension, on chromatin
regulation and epigenetic processes. Collectively, these studies will enhance the annotation of genomic
variants and facilitate the development of more precise, personalized approaches to disease management
and treatment, ultimately improving the well-being of affected children and offering support to their families.

Public health relevance
Kleefstra Syndrome is a rare genetic neurodevelopmental syndrome resulting from EHMT1 gene haploinsufficiency, presenting with intellectual disability, developmental delay, facial features, and childhood hypotonia, often co-occurring with autism spectrum disorders. Studying the impact of EHMT1 genomic variants on its protein structure and function is crucial for advancing our understanding of Kleefstra Syndrome and potentially improving therapies to benefit affected patients. Ultimately, these findings may have broader relevance for addressing neurodevelopmental disorders, enhancing public health efforts in this field.